Imaging Structure and Function Core

PROJECT SUMMARY
Imaging technologies such as confocal microscopy, multiphoton microscopy as well as optical coherence
tomography and adaptive optics have transformed the ability of scientists to observe structural and functional
changes in the visual system, in vivo and ex vivo, in both health and disease. The overarching goal of the imaging
core is to transform the ability of vision scientists to use these critical technologies by providing access to and
training on the newest imaging modalities, and transferring novel approaches between groups to facilitate
innovation in research and collaboration across vision research disciplines. This goal will be achieved through
supporting (1) access to new confocal and OCT/in vivo fluorescence microscopes as well as custom adaptive
optics imaging ophthalmoscopes that will be made available through the Ophthalmology Department, (2) access
to advanced imaging modalities available through various Stanford Microscopy Facilities, and (3) development,
application and dissemination of customized in vivo imaging approaches and systems developed by investigators
in the vision research center.